Protocols to ascertain adverse events after telehealth sexual and reproductive health services

Project Summary
This mentored Ruth L. Kirschstein National Research Service Award will provide the trainee, a PhD student in
epidemiology at UCSF, with the training necessary to become a researcher in sexual and reproductive health.
Her training goals for this fellowship are to gain expertise in health services research, bias analyses, and
methods to address missing data under the guidance of a team of expert mentors. This fellowship will provide
the applicant with the skills, content knowledge, and practical experience to launch an independent research
career focused on the evaluation of service delivery innovations in sexual and reproductive health.
Telehealth became a prominent method of sexual and reproductive health service delivery during the COVID-
19 pandemic. In telehealth services, patients are typically screened remotely, dispensed any medications by
mail, and followed subsequently to monitor for the occurrence of adverse events. Some research suggests that
telehealth patients may be less likely than those who receive in-person services to follow up with the telehealth
provider after medications are dispensed, and the outcomes of patients who do not complete follow-up are not
understood. The goal of this research is to evaluate the performance of telehealth protocols at identifying
adverse events. Building on the applicant’s prior work and current research position, this F-31 will involve
secondary analyses of data from a cohort study of patients who received telehealth sexual and reproductive
health services, to (Aim 1) estimate the incidence of adverse events among patients who do not return for
follow-up and (Aim 2) assess the timing and process of adverse events diagnoses after telehealth sexual and
reproductive health services. This evidence will allow telehealth sexual and reproductive health providers to
understand the risk of adverse events among their patients who do not return for follow-up and whether their
current follow-up protocols are optimal for the identification of adverse events. Knowledge gained from this
research will advance NICHD’s mission to ensure individuals are born healthy and wanted and that women are
not harmed by reproductive processes. The major strengths of this proposal are that it: (1) relies on a large
existing prospective dataset of US telehealth sexual and reproductive health patients, with which the applicant
already has experience; (2) uses rigorous methods for evaluating bias and addressing missing data; and (3)
tests clinically impactful hypotheses focusing on the timely and growing field of telehealth for sexual and
reproductive health. The proposed research and training will prepare the applicant for her future career as an
independent researcher focused on service delivery innovations in sexual and reproductive health care.

Public health relevance
Project Narrative The COVID-19 pandemic brought about an increase in the use of telehealth for sexual and reproductive health services. However, the role of follow-up protocols in identifying adverse events among telehealth patients is not well understood. This study will evaluate the performance of telehealth sexual and reproductive health follow- up protocols in identifying adverse events. These results will inform the development of telehealth clinical protocols that are cost-effective, patient-centered, and safe.